Center for Biomolecular Structure (CBMS)

Abstract - Overall Core
Brookhaven National Laboratory (BNL) has
developed a world-leading suite of experimental
facilities for the life-science research community.
Much of it is organized in the Center for
Biomolecular Structure (CBMS), which has a focus
on macromolecular crystallography (MX) and x-ray
scattering. We propose the addition of x-ray
footprinting (XFP), as a mature complementary
technique, to the resources available within CBMS.
We exploit the unprecedentedly small, bright, and
well-collimated x-ray beams of National Synchrotron
Light Source II (NSLS-II) with experimental stations
that provide the best possible crystal-diffraction and
x-ray scattering data with high levels of automation.
Our responsibility to the users is to enable
hypothesis-driven research by having sufficient
throughput to support high-volume systematic
studies, and with the capability, through our Figure 1: An integrated suite of biophysical techniques
assembly of diverse beamlines, to support multi- working together to enable world class science.
disciplinary work for complex investigations.
We will make these remarkable instruments available to the widest possible community to encourage a
passionate, diverse user community enabling their success and ours.

Public health relevance
Project Narrative - Overall Core The Center for Biomolecular Structure (CBMS) presents state-of-the-art structural biology facilities at the National Synchrotron Light Source II (NSLS-II) to the world-wide community of researchers interested in the study of biological structure. These facilities include 1. micro-beam and highly automated macromolecular crystallography, 2. several modes of x-ray scattering from non-crystalline material, including from solutions, scattering images from tissues, and others, and 3. synchrotron x-ray footprinting of biological materials.